Research Projects Core

Project Summary/Abstract
The UPR Phases 1 and 2 CCfN significantly contributed to advancement of research in Puerto Rico. A key
component has been the investigator-initiated research projects: Phase 1 and 2 Subprojects, and Phase 2 Pilot
and Collaborative Seed Projects. The CCfN supported a total of 21 investigator-initiated research projects: 10
Subprojects, 4 Pilot, and 7 Seed projects. These projects impacted scientists from 5 institutions and 8 academic
departments. These entailed a rich diversity of Neuroscience research themes, experimental model systems,
approaches and methodology. In terms of scientific productivity COBRE-funded PIs (Subprojects, Pilots and
Seeds) accounted for ~50% of the 113 total publications of the CCfN and contributed to 41% (745) of the citations
total (1816). A total of ~$15M in external funds were obtained by these investigators. Subprojects accounted for
52 of the 83 grants submitted (~63%) and 27 of the 48 funded (~56%). COBRE Phase 2 Pilot and Seed projects
accounted for 37.4% of grants submitted and 43% of grants funded for ~$4,25M or 36.3% of the total external
funds obtained by these projects. Phase 3 CCfN seeks expansion and evolution of investigator-initiated research
into a Research Projects Core (RPC) that further evidences the inherent and emerging synergism between the
CCfN’s Administrative Core, Neuroimaging and Electrophysiology Facilities (NIEF), and Research Projects Core.
Phase 3 RPC specifically aims to: (1) continue providing support for investigator-initiated research
projects in the modalities of Pilot and Seed projects. RPC will continue support of Pilots and Seed projects,
with an expanded potential user population and academic institutions. Scope will also be expanded to more
Neuroscience-related research themes and entrepreneurship. Most importantly, all Seed Projects funds
(5K/Seed, 25K/yr, 125K complete grant cycle) and equipment purchases during the first year of each Pilot project
will derive entirely from institutional commitment funds; (2) further enhance the development of COBRE
investigators’ productivity and competitiveness by their participation in programmatic activities
sponsored by the Administrative and NIEF Cores. Pilot Projects participants are required to participate in the
capabilities’ enhancement activities of the Administrative CORE and other applicable NIEF education and
training sessions; and, (3) sponsor the submission of Neuroplasticity and related neuroscience research
grants to competitive sources of research funding, including individual, multiple-PI, program project or
center grants from other NIH Institutes and Centers, or other Federal and non-Federal entities. We aim to
facilitate submission of multiple-PI, program project, or center grants based on areas of research strength. Given
our diversity of neuroscientists and expertise we envision their coalescence into next-level collaborative research
venues. The RPC will further the programmatic goals of fostering development of researchers, enhancing
competitiveness, promoting continued development of a competitive research culture, and becoming a world-
recognized self-sustainable Center for Neuroplasticity with emerging translational/therapeutic applications.

Public health relevance
Project Narrative The Research Projects Core (RPC) of the COBRE Center for Neuroplasticity will facilitate the discovery of new approaches and agents to combat diseases affecting the nervous system like Alzheimer’s, Parkinson’s and disabilities resulting from nervous tissue trauma and injury. This Core integrates enthusiastic scientists using diverse model systems and strategies in modern world-class facilities to better understand how the brain and the nervous system adapt to challenging changes during health and disease. The scientific activity will also nurture the next generation of neuroscientific leaders.